Local Tumoral Delivered Immune Checkpoint Blockades Immunotherapy and Radioembolization Combination Therapy

PROJECT SUMMARY
Systemic mono- or combination- immune checkpoint blockade (ICB) immunotherapy has been an established
therapeutic paradigm. However, a risk of serious autoimmune side effect has been evidenced with non-specific
cytotoxic T cell expansion. Substantial research has investigated into how best to harness the antitumor
potential of combination immunotherapies and how to direct immunotherapies at the tumor. Hepatocellular
carcinoma (HCC) is the 5th most common malignancy in the world and the 4th leading cause of cancer death in
the US. Resection and transplantation are the sole potentially curative treatments for HCC, but only 10-15% of
patients are candidates. Recent clinical trials demonstrate the potential of ICB antibodies against programmed
cell death 1 (PD-1) or its ligand PD-L1 for the treatment of HCC. However, the strong immune suppressive
microenvironment and low expression of immune checkpoint molecules within the HCC tumor lead to a
resistance to immunotherapy in HCC; thus, the efficacy of ICB immunotherapy may not be sufficient to elicit
durable clinical benefits. 90Y-radioembolization (90Y-RE) can precisely deliver high doses of radiation to HCC,
protecting healthy tissues and avoiding side effects. 90Y-RE should be an ideal complement to ICB
immunotherapy given that 90Y-RE induces immunogenic cell death. Recently clinical trials have been initiated
to evaluate systemic ICB immunotherapy in combination with 90Y-RE in the hope of enhancing overall
therapeutic effects. However, one limitation that accounts for the compromised efficacy of combined ICB
immunotherapy is off-target binding of the ICBs to normal tissues upon systemic administration. Ideally these
ICBs should be delivered selectively to the tumor lesion to avoid systemic non-specific activation of the
immune system. We propose catheter-directed intra-arterial (IA) infusion of anti-PD-L1 (aPD-L1) loaded Au
supra-nanostructures (AuSN) in a combination with 90Y-RE. Catheter directed local infusion of aPD-L1 with
high surface area and reactive oxygen species responsive degradable AuSN will augment the localization of
immunotherapy to the targeted HCC permitting radiation-enhanced activation of the immune system for
superior therapeutic outcomes. Our proposed tumoral IA infused anti-PD-L1 loaded AuSN will permit efficient
and targeted delivery of immunostimulatory aPD-L1 to allow an increase in the dosage and improved safety
profile. The local ICB delivery of AuSN carriers will offer the potential to significantly increase the local immune-
stimulating efficacy of 90Y-RE. Our CT visible AuSN and cross-sectional CT and MR image guidance should
also permit us to monitor/track/quantify the delivery of aPD-L1-AuSN to the targeted tumor tissues. It should
allow early prediction of elicited responses to prompt timely adjustments to individual treatment regimens.
Through a collaborative project, we seek to develop a powerful new approach for tumor directed local
combinational aPD-L1 immunotherapy and 90Y-RE for the treatment of HCC.

Public health relevance
NARRATIVE We propose transcatheter tumoral intra-arterial delivery of immune checkpoint blockades (ICB) loaded multifunctional carriers permitting combinational local ICB immunotherapy and 90Y-radioembolization (90Y-RE) of liver cancer. Selective transcatheter tumoral intra-arterial delivery of ICB loaded Au (gold) supra-nanostructures (AuSN) will permit efficient local delivery of immunostimulatory ICB molecules, allowing an increase in the dosage and improve their safety profile. Local tumoral delivered ICB loaded AuSN will offer the potential to significantly increase the radio-immune-stimulating efficacy of 90Y-RE. This salient combination of local ICB immunotherapy and 90Y-RE using the multifunctional carriers offers the potential to significantly improve longitudinal treatment outcomes in liver cancer.